Statistical Design and Analysis Core

The Centralized Statistical Design and Analysis Core (referred to as Core) plays a pivotal role in developing
collaboration and coherence across three distinct projects within the program project. From the outset, the Core
communicates closely with each project, ensuring detailed planning to optimize statistical power and minimize
unnecessary animal use. As data accumulates, the Core employs a harmonized data analysis strategy, utilizing
advanced statistical tests, cutting-edge visualization, and quantitative modeling methodologies. This approach
creates a collaborative environment that facilitates robust insights, enhancing the collective understanding of
radiation exposure effects and the effects of mitigator agents. The Core is instrumental in refining experimental
design, hypothesis testing, and aligning statistical analyses with research questions, predominantly utilizing R,
SAS, and Python languages. The Core's specific aims are summarized as follows: Develop comprehensive
experimental designs and statistical analysis plans that harmonize approaches across three projects,
investigating mitigator efficacy under various radiation types and organ systems. This standardization aims to
facilitate data interpretation. Additionally, the Core works to standardize data workflows, establishing a common
format for data collection across projects and creating a central database for efficient storage. The data repository
enhances computational reproducibility, enabling secondary analyses and coherent synthesis of mitigator
efficacy. Furthermore, the Core performs and guides statistical analyses to align with project objectives, ensuring
the standardized dissemination of results. The Core's involvement in analyses and result interpretation
contributes to the overall coherence of the projects. Its impact is crucial to the coherence of experimental designs,
analyses, and results across the three supported projects, significantly influencing the evaluation of radiation
mitigator effects and harmonizing efforts across diverse projects focused on distinct organ systems and radiation
types in rat models.